Precision Brain Health Monitoring for Alzheimer's Disease Risk Detection in the Framingham Study: Black & AA Recruitment Supplement

Project Summary
This supplement seeks to explore alternative approaches to the recruitment and retention of Black
American participants in AD/ADRD research utilizing digital assessments. Black Americans are
underrepresented in the FHS cohort, which is predominantly non-Hispanic White. Participants who self-
identify as Black represent only 1.7% of the FHS cohort, whereas they comprise 5.2% of Middlesex
Country, which includes the town of Framingham and surrounding communities; this is lower than what is
found within the state of Massachusetts where, the Black Americans comprise 9.3% of the total population.
AD/ADRD affects Black Americans at higher rates than non-Hispanic Whites, which makes it essential that
they be included in research, but recruitment efforts are limited in their success. One widely described factor
making recruitment of Black Americans challenging is the lack of trust in scientific research subsequent to
the historical abuse of this population by the U.S. government and scientists, and so we are centering the
fostering of trust in our approach. We intend to work with two experts in Black community engagement to
facilitate our efforts. Our first aim involves making connections with local Black leaders to have discussions
about the needs of the community and how we can contribute to the needs so we might foster trust and
collaboratively design an effective recruitment/retention protocol. The second aim is to implement and
evaluate this newly developed recruitment/retention protocol by soliciting feedback from community
members for whom the protocol was successful (increased interest in learning about the research) as well
as from those for whom the protocol did not foster interest in engagement. We will revise the protocol based
on this feedback, employ the revised procedures, and re-evaluate. The third aim is to ask those who
expressed interest in learning more about our research to evaluate the digital data collection protocol and
give feedback on which parts they would, and which they would not, be willing to do. They will then be
invited to participate in our digital data collection study to increase representation of Black Americans. We
anticipate collecting digital data from between 119-314 Black American participants.

Public health relevance
Project Narrative The primary object of this supplement request is to develop, deploy, and evaluate the effectiveness of a community engagement approach in the recruitment and retention of Black American participants in AD/ADRD research. Secondarily, we will collect digital cognitive data that will be integrated with the parent study data to create a dataset from between 119-314 Black American participants.